The Role of BCL-2 in Corneal Epithelial Cell Shedding

DESCRIPTION (provided by applicant): The primary objective of this proposal is to gain the necessary training to develop into an independent investigator, integrating my background in the vision sciences with the fundamentals of molecular biology. This objective will be met by a combination of didactic and practical laboratory training under the guidance of mentors Dr. James V. Jester, Dr. H.Dwight Cavanagh, and Dr. Jerry W. Shay. The second objective of this proposal focuses on acquiring the knowledge and molecular techniques required to answer the hypothesis that: nuclear localization of the pro-survival oncogene, BCL-2, is responsible for regulating the final stages of corneal epithelial differentiation and apoptosis. Surface cell apoptosis is a critical component to the maintenance of corneal epithelial homeostasis and is thus a prerequisite for clear vision. In the normal human, the anti-apoptotic protein, BCL-2, localizes to the nucleus and disappears prior to surface cell apoptosis, suggesting a role for BCL-2 in mediating surface cell shedding. Telomerized human corneal epithelial (hTCEpi) cells have also been shown in culture to exhibit disappearance of nuclear BCL-2 prior to apoptosis, thus providing a novel model for studying the mechanism(s) responsible for regulating epithelial desquamation in vitro. In this proposal, this model will be used to examine four specific aims: 1) That an hTCEpi construct recapitulates normal human corneal epithelial cell differentiation and shedding regarding expression, localization, and disappearance of BCL-2 prior to TUNEL labeling. 2) That enhanced expression of BCL-2 results in increased cell survival, persistence of nuclear BCL-2 localization, and decreased surface cell shedding, whereas reduced expression of BCL-2 results in decreased cell survival, loss of nuclear BCL-2 localization, and increased surface cell shedding. 3) That the regulatory loop of BCL-2 and the serine 70 phosphorylation site are critical to regulating surface cell shedding. 4) That events leading to increased apoptosis such as UV light signal surface cell apoptosis through the phosphorylation of BCL-2.